Childrens flame retardant exposures measured by passive wristbands: Sex specific associations, social adversity, and socio-cognitive development

Project Summary/Abstract
This project addresses both bioethics research and capacity building in bioethics. Providing participants in
scientific studies with personalized reports based on data is a bioethical issue and an inexpensive strategy to
increase health literacy, engagement, and trust in research, improve access to scientific information especially
within marginalized communities, and motivate health behavior change. While report back strategies have
been used in health studies, there is a need to assess participant preferences and for report back strategies that
address a child’s exposome (e.g., chemical and social environments) and developmental progress more
holistically. Moreover, an exposome-based strategy must be trauma-informed to appropriately engage parents
of young children who experience adversity. This administrative supplement will support the development of
trauma-informed health messaging and report back strategies by engaging with the existing cohort of parent-
child-teacher triads that have been recruited in “Children’s flame retardant exposures measured by passive
wristbands: sex specific associations, social adversity, and socio-cognitive development” (R01 ES029497). Our
rationale for this additional research is assess parent preferences to thoughtfully inform development of health
messaging and report design that includes trauma-informed approaches (e.g., coupling stressors with
protective influences; inclusive language; multiple ways to engage) combined with personalized reports will: i)
make information more accessible to all families, especially to those facing adversity, ii) increase engagement
with scientific information through the inclusion of their own child’s data and progress, and iii) empower
individuals to make behavioral changes that promote healthy child development. This research will focus on
developing and improving messaging that could be utilized in a future behavioral intervention that would
accelerate research translation for children’s environmental health.

Public health relevance
Public Health Statement The proposed research will provide new information and strategies for trauma-informed health messaging and report design that ultimately seeks to promote healthy child development. This research will focus on quality improvement of messaging that could be utilized in a future behavioral intervention that would accelerate research translation for children’s environmental health.